Sexual Health Empowerment for Jail-Involved Women's Health Literacy and Prevention

ABSTRACT Shawana Moore, DNP, CRNP, WHNP-BC, Assistant Professor in the College of Nursing at Thomas Jefferson University in Philadelphia, is an ideal candidate for a diversity supplement on the parent grant 2R01CA181047, Sexual Health Empowerment for Jail-Involved Women's Health Literacy and Prevention (PI Megha Ramaswamy). As an early stage investigator, Dr. Moore's long-term career goal is to be an independently-funded clinical researcher focused on improving the health of vulnerable and underserved women through innovative intervention strategies. The specific objective of Dr. Moore's proposed subproject is to develop an electronic literacy intervention focused on the prevention of cervical cancer through implementation of HPV catch-up vaccination among criminal legal system-involved women aged 27-45. Dr. Moore will work closely with her primary mentor, Dr. Ramaswamy, and her mentor team, Dr. Mugur Geana and Dr. Patricia Kelly, to reach this long-term career goal and specific objective by increasing her qualitative research knowledge and skills, by building technical skills in electronic intervention design and evaluation, by collaborating on dissemination activities, and by expanding her professional networks in cancer prevention and criminal justice/health research. The diversity supplement project will be embedded within the parent grant that already has a platform, called `SHE-WOMEN' for delivering health literacy information to women with criminal legal system involvement around cervical, breast health, sexually transmitted infection, and unintended pregnancy prevention. The specific contribution of this diversity supplement is the development of an electronic intervention module that 1) specifically targets HPV vaccine `catch up' literacy (our average age of participants is 35 years old - we estimate that two-thirds would be eligible for vaccine catch up, based on not having gotten the vaccine when they were younger, for a variety of reasons), and 2) provides tools for discussing catch up vaccine with providers to address the shared clinical decision-making recommendation for catch-up vaccine. Findings from this subproject will support the adaptation of the SHE WOMEN intervention to include an HPV vaccine catch-up navigation module, with potential relevance for other high risk groups and topics. Additionally, the subproject will provide Dr. Moore experience in the development of electronic interventions, delivery and evaluation, qualitative data analysis, as well as the enhancement of a scholarly track record and new networks for career support and success. Ultimately the diversity supplemental will serve as tool in Dr. Moore's pathway to an independently funded clinical researcher focused on addressing the health needs of women with criminal legal system involvement.

Public health relevance
PROJECT NARRATIVE Women involved in the criminal legal system are four-five times as likely to have cervical cancer, a preventable cancer caused by infection with Human Papillomavirus (HPV). While the Advisory Committee on Immunization Practices currently recommends catch-up HPV vaccination for persons aged 27-45, minimal education is available to this population about the benefits of HPV vaccine for the prevention of cervical cancer. The diversity supplement candidate, Dr. Shawana Moore, will address this specific public health problem while gaining skills, disseminating, and broadening her research networks for future success.